K-INBRE Administrative Core

PROJECT ABSTRACT
The Kansas INBRE (K-INBRE) network proposes an Administrative Core to oversee operations of the
statewide K-INBRE program. The long-range objective for the Administrative Core is to provide leadership,
oversight, financial and reporting duties, and oversee the evaluation components of the K-INBRE program. In
addition, this Administrative Core houses 2 key components of the K-INBRE program that include oversight
and decision-making of the funding selections (Incentives and Awards Committee) and oversight, tracking, and
scholarship associated with undergraduate research opportunities (Undergraduate Research Office). Our
purposes are to provide professional oversight to maintain this long-standing and highly functional statewide
program, and to expand and integrate with existing educational and training programs operating in Kansas.
The Administrative Core will function through the following 3 Aims: 1) provide administrative oversight to the
overall K-INBRE program, 2) provide oversight and assistance to the two working committees in the
administrative core and 3) expansion of the K-INBRE pipelines into existing development programs in Kansas,
including high schools.
A strength of the K-INBRE Administrative Core is the longstanding continuity and success of the
experienced leadership and administrative personnel. The major functions of the Administrative Core continue
to adjust to meet all compliance requirements for NIH. The Incentives & Awards Committee oversees decisions
on funding and supervision of all awards within the K-INBRE. The Undergraduate Research Office supports
biomedical research experiences for undergraduates on K-INBRE campuses. This Office will oversee
programs directed by the 10 Campus Coordinators to attract and retain promising students into biomedically-
related science majors and to involve these students in cutting edge research; and assist in the implementation
of student focused symposia and workshops, and supervise the award of funds to support in unique
undergraduate training opportunities. A new innovation for the current iteration of the K-INBRE is an expansion
of our workforce training pipeline into the level of high school students, as well as new integration with current
and existing educational and training programs in the state of Kansas. These new features will augment the
success of these Kansas programs and provide access to our expansive number of K-INBRE faculty
participants and laboratories.